Community Partnership

ELEVATE CENTER COMMUNITY PARTNERSHIP PROJECT SUMMARY
The mission of the ELEVATE Center is to Expand our reach across Utah and the Intermountain West,
LEVerage existing infrastructure, And Treat pregnant and postpartum people with substance use disorder
(SUD) who experience disparities to achieve Equity. We have intentionally positioned achieving equity as a key
outcome of the ELEVATE Center’s mission and recognize this requires an approach that upends traditional
research structures, radically altering the parameters of community engagement and partnership.
When working with historically and structurally marginalized people, research efforts are most successful when
investigators collaborate with community partners and people with lived experience from the outset. This is
particularly critical when working with communities with intersecting identities. Pregnant and postpartum people
with SUD, particularly Native mothers or those in rural areas, experience numerous structural barriers to health
and are the focus of the ELEVATE Center’s projects. Explicitly sharing authority over the direction and
interpretation of the Center’s research efforts engenders trust, thus amplifying the reach and impact of results.
ELEVATE Center investigators are engaged in long-standing community partnerships that center communities
and people with lived experience. These long-standing community partnerships create the foundation for the
ELEVATE Center’s Community Engagement Integration Core and the Community Advisory Board (CAB)
embedded within the Core. Our strong partnerships provide a springboard for realizing our long-term goal of
conducting community-integrated research that amplifies community wisdom and leadership to eliminate
inequities in maternal morbidity and mortality in Utah. The Community Engagement Integration Core will
support the ELEVATE Center’s objectives by providing a central, responsive infrastructure that cultivates
community partnerships predicated on equitable leadership, community wisdom, and resilience. Our aims are
to: (1) develop structures that amplify and coordinate community voices to create equitable leadership in the
efforts of the ELEVATE Center; (2) accelerate the maturation of networks between and across the ELEVATE
Center’s community partners to facilitate innovative implementation of research and training efforts; and (3)
build robust dissemination pathways and sustainability structures on the scaffold of the ELEVATE Community
Engagement Integration Core’s infrastructure.
Regular CAB and Community Engagement Integration Core meetings, virtual connection resources,
coordinated trainee and participant recruitment, and capacity building trainings will ensure ongoing
collaborative work across all participating Center investigators and our community partners. The ELEVATE
Center’s Community Engagement Integration Core will centralize infrastructure, provide avenues for
bidirectional knowledge exchange and community leadership, and amplify dissemination efforts. Collectively,
these actions will maximally and sustainably reduce maternal morbidity and mortality from SUD in Utah.